THE EVOLUTION OF PGD ADDICTION IN HUMAN PANCREATIC CANCER

PROJECT SUMMARY (ABSTRACT)
Distant metastasis is the cause of most cancer deaths. This is particularly true for pancreatic cancer. These
patients develop hundreds to thousands of metastases that appear suddenly and progress rapidly to fill the
liver and lungs. This stage of the disease is rapidly lethal, poorly understood, and grossly understudied.
Long-term Objectives: Characterize what drives and/or accelerates the metastatic stage of pancreatic cancer
in patients, and use this knowledge to design new and effective treatment strategies.
Research Design: This proposal is designed to deeply characterize how a metabolic enzyme named PGD
drives pancreatic cancer metastasis. We recently discovered that sugar (glucose) activates PGD, and once
PGD is activated it strongly stimulates metastatic tumor growth. Understanding how cancer cells use glucose
to activate PGD and how PGD then promotes tumor growth is important: it could lead to the first effective
treatment strategies against the most common and most lethal stage of disease progression.
Research Methods: Experiments will use a powerful set of metastatic pancreatic cancer cells and tissues that
were collected from individual patients who died of the disease. Unique three-dimensional experimental
platforms will allow us to investigate how these cancers learned to form metastatic tumors in the patients.
Experiments will specifically focus on how the metastatic cells process glucose into metabolites that activate
the PGD enzyme, and how the activated PGD enzyme is then able to enhance metastatic tumor growth.
Aim 1: Determine how glucose fuels high PGD catalytic activity in distant metastases.
Aim 1 will investigate how an unusual series of metabolic reactions convert glucose into metabolites that
activate PGD. Our recent work was the first to detect these reactions in humans. That is because they are only
operational in the metastatic cancer cells. Their function is to support PGD-driven metastasis.
Aim 2: Define the mechanism whereby PGD is constitutively activated in distant metastases.
Aim 2 will investigate how activated PGD is able to accelerate the rates of both glucose consumption and fatty
acid biosynthesis in the metastatic cancer cells. This not only strongly promotes metastatic tumor growth, but
also maintains PGD in a perpetually activated state that cannot be switched off in the presence of glucose.
Aim 3: Investigate how PGD reprograms the epigenome to activate the metastatic transcriptome.
Aim 3 will investigate how PGD is able to control the “epigenome”, which refers to small chemical modifications
within chromatin that regulate expression of the genes encoded in the DNA sequence (the “transcriptome”).
PGD reprograms the pancreatic cancer epigenome by accelerating glucose consumption. The metastatic cells
break the extra glucose down into the smaller epigenetic chemicals. The chemicals are then used to increase
expression of numerous genes that enhance metastatic tumor growth and bestow treatment resistance.

Public health relevance
Project Narrative A diagnosis of pancreatic cancer is nearly always a death sentence, and this disease is projected to become the second-leading cause of cancer deaths in the western world over the next decade. This is because most patients develop widespread metastatic disease that progresses rapidly and is treatment-resistant. Here we propose to solve key mechanisms that drive this aggressive disease, by investigating how human pancreatic cancers learned to harness sugar (glucose) in unique ways to fuel metastatic tumor growth in patients who died from widespread metastasis.